Center for Climate: Equitable and Accessible Research-based Testing for Health (C-EARTH)

Climate change is increasing temperature variability and extremes, causing both direct effects on health (e.g.,
death, heat stress) and indirect impacts on food and water supplies. Research by our team and others has
clearly demonstrated that climate change disproportionately affects individuals and communities that
experience social and environmental vulnerabilities and discrimination. There is a critical need for evidence-
based solutions to reduce the impacts of the warming climate on marginalized communities to enable timely,
effective, and impactful interventions. The Center for Climate: Equitable and Accessible Research-based
Testing for Health (C-EARTH) will catalyze transdisciplinary research approaches involving individual- and
policy-level solutions to address multiple climate risks to human health, particularly in populations at greatest
risk, reflecting our environmental justice and health equity goals. The aims of C-EARTH are to: 1) create new
research capacity for the development and evaluation of climate change and health (CCH) solutions to address
the consequences of heat and improve health equity, catalyze collaborations across disciplines, support career
development of early-stage investigators, oversee a community-based pilot grant program on CCH solutions,
and provide data infrastructure and heat tracking systems (Administrative Core); 2) identify climate-related
health effects and test CCH evidence-based solutions among the most marginalized and at-risk members of
society in partnership with community health workers and non-profit organizations in Boston, Madagascar, and
South Africa (Research Project); 3) engage with community partners to cultivate trust, communication, and
shared decision-making towards implementing community-based climate solutions that improve health
inequities (Community Engagement Core); and 4) catalyze CCH implementation science and participatory
research to implement and evaluate evidence-based solutions to address CCH and improve health equity by
providing qualitative and quantitative analytic support, policy translation, and capacity-building initiatives for
researchers and local leaders (Implementation, Solutions, and Evaluation Core). The C-EARTH leadership,
research, and multidisciplinary support team brings complementary expertise in community engagement,
environmental and population health research, nutrition, implementation science, cost-benefit analyses, health
equity, and national and international climate policy – thus enabling transdisciplinary solutions-oriented
research. C-EARTH will be instrumental in building the capacity to develop and test culturally sensitive
evidence-based solutions for climate justice in high-risk and marginalized communities around the world, with
opportunities for replication and scalable solutions to maximize impact.

Public health relevance
Climate change disproportionately affects individuals and communities experiencing social and environmental vulnerabilities and discrimination. There is a critical need for evidence-based solutions to reduce the impacts of the warming climate on marginalized communities to enable timely, effective, and impactful interventions. We propose to establish the Center for Climate: Equitable and Accessible Research-based Testing for Health (C- EARTH) to catalyze transdisciplinary research approaches involving individual- and policy-level solutions to address multiple climate risks to human health in high-risk and marginalized communities around the world.